CRCNS: Unraveling the visual system's temporal code for dynamic scene processing

Our brain's ability to instantly recognize an object within a visual scene is almost effortless, yet obtaining
this ability in artificial visual systems has taken decades. This is because the brain's computations that
transform a visual scene into a neural code remain hidden among the billions of neurons and synaptic
connections that make up the human visual system. Identifying and understanding these computations is
the first step in providing clinical diagnoses and treatments for diseases and disorders disrupting visual
processing, ranging from transient motion sickness to neurodegenerative disorders such as posterior
cortical atrophy. Such treatments may involve visual prostheses to replace or bypass damaged
computations (e.g., those involved in motion processing or face detection). Decades of experiments and
modeling have uncovered fundamental computations in early visual cortex (retina, LGN, V1), but our
knowledge of spatial feature processing (shapes, textures, colors) and temporal processing (motion,
changing perspective) in higher-order visual cortex (e.g., areas V4 and IT) remains limited. This proposed
research program aims to characterize the neural computations involved in how visual cortical area V4
neurons respond to dynamic video clips. We will build a computational model that accurately predicts
temporal V4 responses and interrogate this model to isolate the model circuits that govern the temporal
integration of visual features. To optimize the parameters of our deep neural network model, we will
combine data collection and model training in a closed loop: We train our model after each recording and
choose the next video clips to present based on the model's uncertainty. In other words, we keep refining
our working hypothesis---a deep neural network model---through model-guided data collection. The result
of this procedure will be a large-scale dataset of temporal V4 responses to natural video clips as well as a
highly-predictive computational model. We will use this model to test whether feature attention
dynamically modulates V4 responses, linking temporal feature integration to behavior. Overall, this
innovative closed-loop approach, requiring close interdisciplinary collaboration between experimental and
computational researchers, promises to unlock the neural computations involved in spatial and temporal
feature processing in higher-order visual cortex.

Public health relevance
RELEVANCE (See instructions): Disease and injury to the visual cortex results in profound impairments in vision that impact daily life. It is increasingly clear that to improve the diagnosis of visual disorders, as well as to build effective visual prostheses to repair visual dysfunction, we must understand the neural computations of the visual system. The proposed research aims to identify these computations by large-scale neural recordings and advanced AI modeling to improve our understanding of the visual system and its disorders.